Antiviral lung resident memory T cell maintenance and reinvigoration

PROJECT SUMMARY
Seasonal influenza A (IAV) and other airborne viral pathogens such as SARS-CoV-2 represent a substantial
burden on global public health. While sterilizing immunity can be attained through neutralizing antibodies,
seasonal antigenic drift permits viral evasion of humoral immunity, which necessitates annual reformulation of
the seasonal influenza vaccine. It has previously been shown, that cross-reactive CD8+ T cells can provide
heterosubtypic non-sterilizing immunity to IAV. However, this cross-protection is relatively short-lived in the
context of a singular antigen exposure. Our lab has shown that lung tissue resident memory T cells (lung Trm)
contribute to this strain transcending cross-protection and that the waning in numbers of IAV-specific Trm strongly
correlate with this loss of IAV cross-protection. Importantly, we have found that multiple exposures to the same
IAV antigens (boosting) can extend the longevity of these lung Trm populations, and as a result, provide extended
heterosubtypic immunity. There still exists a substantial knowledge gap regarding why lung Trm cells are so short
lived when they are clearly important for protection. Addressing this question remains a critical step in the rational
design of universal influenza vaccines. Our long-term goal is to understand the biology that underlies the
waning of lung Trm cells and to harness this information to aid in the development of broadly protective
influenza vaccines. We will address this long-term goal with the following specific aims:
Aim 1: Determine the molecular T cell intrinsic factors that permit extended longevity and functionality of lung
Trm following multiple antigen exposures.
Aim 2: Define the optimal priming and boosting vaccination strategies to maximize Trm generation, re-
invigoration, and function.

Public health relevance
PROJECT NARRATIVE While being critical for protection from respiratory viral infection, lung resident memory T cells (Trm) wane with time; though the cause of this waning remains unclear. Our lab and others have demonstrated that this waning strongly correlates with the loss of heterosubtypic immunity to influenza A virus (IAV), indicating a critical importance for a more detailed understanding of Trm biology. The proposed study dissects the cause of IAV- specific lung Trm waning through functional, transcriptomic, and metabolic studies of T cell biology and defines vaccination strategies to re-invigorate this critical population of cells through innovative and clinically relevant mRNA-based vaccine platforms.